Developing new therapeutic strategies for pediatric tumors that lack clinically actionable mutations

PROJECT SUMMARY / ABSTRACT
Cancer is the leading disease-related cause of death in children. Treatment has remained largely unchanged
in decades, relying primarily on aggressive cytotoxic chemotherapy and radiation—these therapies have
debilitating long-term consequences. Precision medicine has yet to make a major impact on childhood cancer
because, while thousands of pediatric tumor genomes have been sequenced, most children have very few
somatic mutations compared to adult cancers. This means targeted cancer drugs are not an option for most
children and fewer tumor-specific neoantigens means most immunotherapies are ineffective.
However, in the last 5 years, large-scale CRISPR and drug screening studies in cancer cell lines, such as the
Dependency Map (DepMap), have shown that in many cancers, unmutated genes can also act as potent drug
targets. These genes are known as non-oncogene dependencies. The overall goal of this project is to
overcome the low mutation burden, by identifying the druggable non-oncogene dependencies of pediatric
tumors and to perform the requisite in vitro and in vivo experimental work to move these therapies to the clinic.
We will identify these non-oncogene dependencies by applying tools from machine learning to perform
integrative analysis of large pre-clinical screening datasets (such as DepMap, CCLE, and PRISM) with patient
tumor -omics data. This will allow us to nominate specific non-oncogene dependencies for pediatric tumor
subtypes, defined based on, for example, whole-genome gene expression or methylation data. We will
mechanistically validate the top hits using in vitro experimental assays.
Additionally, almost all curative cancer treatments involve the rational combination of multiple therapies,
however, existing methods to predict effective combinations perform poorly when tested on unseen data. Thus,
our second aim is to apply an approach that we have developed based on targeted CRISPR knockout
screening to identify synergistic drug combinations. We will validate these combinations in vivo using mouse
models with patient-derived xenografts, leveraging shared resources already established at St. Jude.
Finally, tumor heterogeneity is ultimately the downfall of every known cancer treatment; however, in pediatric
tumors where the mutation burden is low, much of this heterogeneity is driven by cell state, rather than specific
somatic mutations. We will dissect the influence of cell state on drug resistance using single-cell and spatial
transcriptomics technologies applied to a drug-treated spontaneous mouse model of neuroblastoma. This will
ultimately allow us to nominate new drug combinations explicitly targeting drug-resistant cell states.
Overall, this research program will aim to build a pipeline at St. Jude to overcome some of the main challenges
posed by the low number of somatic mutations in pediatric tumors and identify new therapeutic strategies for
these patients. We have assembled a diverse world-class team of researchers with all components necessary
for an eventual impact on patient care.

Public health relevance
PROJECT NARRATIVE The treatment of pediatric cancers has remained largely unchanged in decades, relying primarily on aggressive cytotoxic chemotherapy and radiation, however, these therapies have debilitating long-term consequences. We will use new computational methodologies applied to large preclinical screening data from cancer cell lines and patient -omics datasets to investigate unmutated genes as potential drug targets in pediatric cancers (non-oncogene dependencies). We will perform the requisite downstream experimental work, including studying drug combinations and resistance mechanisms, necessary to motivate the clinical translation of our findings.